Resource Core

To organize unique resources most powerfully for our Core Center for Clinical Research (CCCR) and foster
approaches to fill research gaps impeding the NIAMS mission to improve health and equity, we propose a
Resource Core, Community Engaged Assessment and Intervention Science and Technology in Daily Life (CE-
ASSIST-Daily Life). We will catalyze growing awareness in our Research Community of the necessity of
community engagement and will target investigators across the translational spectrum. We will improve
efficiency by leveraging hubs of Northwestern University (NU) expertise. In turn, our Core will enrich these
hubs' activities by expanding their portfolios through our unique, content (NIAMS mission)-specific model of
integrated activity. For research focused on persons with or at risk for rheumatic and musculoskeletal
conditions, our aims are: 1) Create and sustain interaction between stakeholders and research teams
through project stages, a) build pathways for ELGLUHFWLRQDO FRPPXQLW\ļDFDGHPLF exchange to increase
research value for improving health and equity by refining research ideas and planning in partnership, e.g.,
through our CCCR Community Advisory Board (CAB), including a community liaison on the Core team,
organizing project-specific Stakeholder-Academic Resource Panels that bring investigators and stakeholders
together to improve research relevance, team composition, design, implementation, and dissemination, b) build
capacity for community-engaged research, e.g., by conducting academic and community outreach, providing
training within CCCR educational activities, and giving feedback on enhancing community engagement to all
CCCR users; 2) Help project teams design research that integrates personal and community perspectives, a)
refine research questions, study design, assessment plan, intervention comparators and intervention
procedures, and assist with budget planning, all in conjunction with the Methodologic Core, b) get stakeholder
input on variables and outcomes that matter most to individuals and collaboratively develop assessment plans
that can include social determinants of health as well as self-report to assess social/physical/mental health,
symptoms, and life satisfaction, performance-based assessment of motor/sensory/cognitive function,
accelerometry to assess physical activity/sedentary behavior/sleep, mobile and sensor-based applications
(e.g., GPS, activity logs) that identify behavioral markers, and wearable biosensors to predict physiological and
psychological states; 3) Help project teams operationalize their research and create dissemination plans for
the scientific community and stakeholders. Because this Core (a) is centered on our goal, to improve how
persons feel and function in their daily lives, (b) focuses on community and personal experience, (c) builds
upon the wearable and portable technology revolution, and (d) integrates outstanding hubs, CE-ASSIST-Daily
Life is well-positioned to have substantial impact on work within and beyond our institution.